Family-Centered Digital Behavioral Sleep Intervention for Black Families of Preschool-Aged Children

PROJECT SUMMARY
Short sleep duration is linked with obesity risk in children.1, 2 The prevalence of short sleep duration is 35%
among American preschoolers (3 to 5-year-olds) and 53% for Black-American children,3 a glaring health
disparity. Sleep disparities in young Black children are hypothesized to be due to social determinants of
health, including structural racism and poverty that permeate multiple socio-environmental levels of children’s
lives, especially through parenting practices.4-6 Establishing a regular bedtime routine has been recognized as
a modifiable parenting behavior to optimize sleep duration. And, digital technology offers an acceptable
platform to reach Black families of young children.7 My long-term career objective is to bridge access of
evidence-based interventions to Black families via dissemination and implementation science strategies
integrated into community systems. My career goal is to become an independent scientist in sleep health
interventions to reduce health disparities through family-centered research. This K01 proposal aims to increase
access of Black parents of young children to evidence-based strategies known to optimize sleep health. My
specific aims are: Aim 1. Develop a digital prototype of evidence-based strategies for establishing a bedtime
routine based on using a mixed methods approach (i.e., focus groups and survey data) that considers the
lived experiences of 20 Black families of 3- to 5-year-olds with sleep problems; Aim 2: Test the feasibility of the
intervention content and digital implementation procedure and iteratively develop the intervention through user
journey methods (i.e., cognitive walk-through and think-aloud sessions), and implementation feasibility
questionnaire with the same 20 Black families engaged in Aim 1; and Aim 3: Test the acceptability and
estimate the impact of the optimized digital intervention through a single-arm pilot study with 40 Black families
of 3- to 5-year-olds with sleep problems. Primary outcomes are: Parent knowledge, parenting practices related
to establishing bedtime routines, child sleep duration and child bedtime resistance. To achieve this objective,
my career development plan includes: 1) obtain training and expertise in behavioral sleep medicine, 2) build
expertise in dissemination and implementation science strategies, related to parent engagement; 3) gain
hands-on experience conducting an integrated family-centered evidence-informed digital sleep intervention to
improve sleep in the family unit; and 4) biostatistical analysis and clinical trial design skills. At NYU Grossman
School of Medicine’s Department of Population Health, I will have access to resources from the Department,
the Division of Health and Behavior, the Center for Early Childhood Health and Development, NYU Langone
Family Health Centers, and the Institute for Excellence in Health Equity, directed by my advisor Dr. Ogedegbe.

Public health relevance
NARRATIVE The prevalence of short sleep duration is 35% among American preschoolers (3 to 5-year-olds) and 53% for Black-American children, a glaring health disparity associated with developmental outcomes in children. This proposed K01 research study will contribute short-term fundamental knowledge about the nature and behavior of parenting practices and behaviors related to bedtime routines to optimize children’s sleep health, by centering the voice of Black families and considering the social determinants of health that filter through Black families that affect child sleep. The application of the knowledge gained in this mixed-methods study, will contribute to the development and testing of a mobile-health, family-centered behavioral sleep intervention for Black families of preschool-aged children to enhance and optimize child sleep health outcomes.